Project outreach, training, education

Over the next grant period, we aim to consolidate the most successful aspects of our program, and build on our experiences to expand the Center's activities in this area, developing new initiatives to increase our capacity for recruitment, retention, and successful completion of training at all career levels.